Pathogen and host predictors of M. tuberculosis transmission

PROJECT SUMMARY
Common ways to measure M. tuberculosis transmission are via acquisition of Th1-skewed T-cell immunity
(e.g., interferon gamma release assays; IGRA) or new TB cases. However, these measurements may
oversimplify and, in some cases, entirely miss M. tuberculosis transmission. For example, a substantial
minority of highly-exposed individuals have T-cell responses to M. tuberculosis antigens that are not Th1-
based. In addition, subclinical or asymptomatic TB is common, but often not captured clinically. Different
strains of M. tuberculosis may have evolved different solutions to optimize transmission, which may associate
with distinct phenotypes. In addition, as M. tuberculosis encounters hosts with different genetic backgrounds,
immune status, age, and sex, the manifestations of infection outcomes may vary, due to both bacterial and
host factors. We hypothesize that M. tuberculosis transmission outcomes are affected by both bacterial and
human host (contact and index case) factors. We will test our hypothesis in the well-established RePORT-
Brazil cohort study of TB cases and their close contacts. There were 1,188 TB cases and 1,930 contacts
enrolled in Phase 1 (2015-2021), and ~1,000 TB cases and ~2,000 contacts will be enrolled in Phase 2 (2022-
2026). We will identify M. tuberculosis bacterial genetic and phenotypic features associated with M.
tuberculosis transmission outcomes, including M. tuberculosis infection, subclinical TB, and clinical TB disease
through bacterial association studies and mechanistic evaluation. We will also define M. tuberculosis
transmission outcomes using multi-parameter profiling of human cellular immune responses in close contacts.
Clinical and epidemiologic characteristics of the close contacts and their index TB cases will also be
addressed, in prediction models of M. tuberculosis transmission that also incorporate M. tuberculosis genetic
and host immune factors. Findings from this study could guide the development of targeted interventions, such
as diagnostics for detecting highly transmissible M. tuberculosis strains, and host-directed therapies aimed at
modulating immune responses to reduce transmission risk. The results will also provide insights for optimizing
public health strategies, including contact tracing and targeted preventive therapy, specifically tailored to high-
transmission settings.

Public health relevance
PROJECT NARRATIVE We will identify M. tuberculosis bacterial genetic and phenotypic features associated with M. tuberculosis transmission outcomes, including M. tuberculosis infection, subclinical TB, and clinical TB disease through bacterial association studies and mechanistic evaluation. We will also define M. tuberculosis transmission outcomes using multi-parameter profiling of human cellular immune responses in close contacts. Clinical and epidemiologic characteristics of the close contacts and their index TB cases will also be addressed, in prediction models of M. tuberculosis transmission that also incorporate M. tuberculosis genetic and host immune factors.